THE ADMINISTRATION CORE (AC)

ABSTRACT FOR ADMINISTRATIVE CORE
The Administrative Core (AC) will support the overall work of the Aging Adult Brain Connectome (AABC) to
establish a focused program that identifies salient variables that affect the trajectory of brain structural and func-
tional connectivity during the lifespan. The AC will organize resources in support of the four Projects and four
Cores that address resilience and vulnerability factors (e.g. genetic risk, environment stress, lifestyle behaviors,
and menopause) that contribute to cognitive dysfunction, brain aging, and Alzheimer’s disease (AD) and Alz-
heimer’s disease related dementias (ADRD). The AC of the AABC will provide the central infrastructure to sup-
port and expand upon the Human Connectome Project for Aging (HCP-A) by continuing to collect longitudinal
data from 1000 individuals across the lifespan. For many participants this will yield a total of 3-4 longitudinal time
points that will be acquired over 8-10 years. The AC will be led by contact PI, Dr. Ances at Washington University
in Saint Louis (WUSTL), and an Executive leadership team of co- PIs from each of four data acquisition sites,
including Dr. Bookheimer at University of California Los Angeles (UCLA), Dr. Terpstra at the University of Min-
nesota (UMinn), and Dr. Salat at Massachusetts General Hospital /Harvard University (MGH). In addition, the
AC includes a new diversity recruitment and retention unit (DRRU) led by Drs. Babulal (WUSTL) and Diaz-
Santos (UCLA). The aims of the AC include: 1) Provide program management of the AABC 2) Provide scientific
direction for the AABC 3) Promote communication among investigators, the external advisory committee (EAC),
and the general scientific community.

Public health relevance
NARRATIVE FOR ADMINISTATIVE CORE The Aging Adult Brain Connectome (AABC) builds on the existing infrastructure previously developed through the Human Connectome Project (HCP) Aging consortium. The AABC will acquire demographic, genetic, physi- ologic, health, and neurocognitive information in conjunction with cutting edge functional and structural neuroim- aging data (magnetic resonance imaging (MRI) and now magnetic resonance spectroscopy (MRS)) from a large cohort of individuals (n=1,000) across the lifespan. The Administrative Core (AC) will support the overarching goal of the AABC to determine the effects of resilience and vulnerability on structural and functional brain con- nectivity trajectories throughout the lifespan. The AC will organize resources in support of the four Projects and four Cores.